Ultrafast optical brain imaging via blurred matrix completion

Summary: Neural computation is a global phenomenon driven by a myriad of local, granular
biophysical phenomena at millisecond time-scales. Advancing our knowledge of neural function
and dysfunction requires new technologies that can capture granular information over large areas
at fast framerates. We propose a new computational imaging approach that combines easily
disseminable optics with algorithmic reconstruction algorithms that will advance the capabilities of
both in vivo two-photon and light-sheet imaging, reaching the >100 Hz framerate range over large
areas and volumes.

Public health relevance
Abstract: The brain is a complex organ consisting of many cell types that interact through many distinct biochemical interactions. Linking molecular-level dynamics to brain-wide information flow requires the ability to interrogate these many local signals, which often fluctuate on timescales as fast as milliseconds, over large areas of the brain. Optical imaging of fluorescent tags has emerged as a key technique in this endeavor, with brighter and faster optical sensors being increasingly improved and expanded to tag biological targets of interest from calcium and voltage to glutamate, dopamine and others. To match these improvements, and anticipate the constant trajectory of future indicators, the next generation of optical microscopy methods must match the speed of the targets of interest while expanding the accessible imaging area. Most current methods primarily focus on expanding the area imaged at typical calcium framerates (30 Hz or slower) through multi-plane and volumetric imaging approaches. Methods to improve speed have also been explored, in particular focusing on pre-selection of regions-of-interest (ROIs), which minimize the time spent imaging areas with little signal. These approaches can improve imaging speed but require pre-selection of ROIs, limiting the ability to freely explore tissue and missing ROIs not presenting strong signals in the short initialization scan, and can be sensitive to motion artifacts---especially those that move the ROI partly or fully out of the imaged area targeting the ROI. As an alternative, we propose a computational imaging technique that combines the speed gains from sub-sampling each frame with the benefit of reconstructing the full FOV. Our approach combines the blurring local information in only one dimension of the scan (i.e., the direction of slowest scanning) and randomly selecting only a fraction of lines for each frame, which are fully sampled. We further leverage the well-used low-rank model of spatio-temporal correlations in fluorescence videos to fill in the missing regions through a matrix completion reconstruction. Our preliminary data shows feasibility of the reconstruction in both two-photon and light-sheet settings, meaning that our conceptual approach is broadly applicable to a range of imaging technologies. Through minimal modifications and development and optimization of the reconstruction algorithm we propose to build and validate 1) a two-photon microscope capable of imaging a 0.5 micon FOV at >400 Hz (Aim 1) and 2) a light-sheet microscope capable of full-brain zebrafish imaging at >200 Hz (Aim 2). We will demonstrate these technologies in densely labeled glutamate imaging in mice (Aim 1), and in full-brain voltage imaging in zebrafish (Aim 2).